Lineage Analysis of Cellular States Predicting Reprogramming into iPSCs

Project Summary
Induced pluripotent stem cells (iPSCs) derived from differentiated somatic cells via ectopic expression of a
cocktail of reprogramming factors are a promising, patient-specific resource for disease modeling and
regenerative medicine. However, only a rare subset of cells (<1%) exposed to the reprogramming factors actually
become iPSCs. Furthermore, we do not know what, if anything, is different about these rare cells capable of
reprogramming. While variability in reprogramming outcomes is often ascribed to technical issues, low
reprogramming efficiency remains even when the reprogramming factors are integrated clonally and stably into
the genome. This suggests that this variability is instead due to single-cell differences in chromatin state, gene
expression, and protein signaling (i.e. cell states). Here, we demonstrate evidence of distinct and stable cell
states in the rare subset of cells “primed” to reprogram. We hypothesize that cells can fluctuate in and out of
these primed states whose acquisition enables successful reprogramming into iPSCs. The underlying goal of
our proposal is to identify, characterize, and eventually manipulate these primed states to increase iPSC
reprogramming efficiency. Yet, identifying post-facto relevant factors marking this rare subset of primed cells
represents a major conceptual and technical challenge. Therefore, we propose to use a cellular “Time Machine”
to rewind back time from the ultimate phenotype to identify cells primed to become iPSCs in the original
population via a novel combination of barcoding, RNA FISH, imaging, and flow sorting. Our preliminary data
demonstrate that this method can label, isolate, and profile specific cells based on their future propensity to
reprogram into iPSCs when exposed to the reprogramming factors. In Aim 1, we will use this method to isolate
cells that would later give rise to iPSCs from several different starting cell types. By performing RNA-seq and
ATAC-seq on the isolated cells, we will identify markers and epigenetic regulators of these primed cells and
validate them functionally using chemical and CRISPR-based perturbations. In addition to baseline
reprogramming, we want to understand how perturbations that increase iPSC reprogramming efficiency (i.e.
boosters) specifically increase the fraction of cells becoming iPSCs. In Aim 2, we will use Time Machine to
isolate and profile the extra cells that give rise to iPSCs only when reprogrammed with booster. We will determine
how they are different from the initial subset of reprogrammable cells without booster by comparing molecular
signatures. Then, we will identify and validate factors mediating reprogramming in these extra cells with a specific
booster or across boosters to molecularly understand how boosters recruit additional subsets of cells to become
iPSCs. This work is poised to answer longstanding questions about the existence and nature of rare cells primed
for reprogramming. More broadly, it will help us identify new pathways to manipulate iPSC reprogramming and
reveal the molecular basis of plasticity in seemingly differentiated cells.

Public health relevance
Project Narrative Induced pluripotent stem cells (iPSCs) derived from somatic cells provide a valuable, patient-specific source for regenerative medicine, drug discovery, and disease modeling, but these clinical applications are limited because reprogramming is slow and inefficient. Only rare subsets of cells go on to become iPSCs upon exposure to reprogramming factors, but if we knew what was different about them beforehand we could design strategies to isolate or generate more for downstream use in clinical applications. Here we propose using a novel strategy combining single-cell barcoding, RNA FISH, imaging, and flow sorting to directly and isolate and characterize rare cells that give rise to iPSCs, enabling us to identify regulators of selective plasticity in differentiated cells with implications in stem cell biology, tissue repair, and cancer pathogenesis.